IMSD AT HUNTER COLLEGE, CUNY

ABSTRACT
This T32 application is for a new multidisciplinary IMSD program at Hunter College, CUNY to support 12
annual trainee positions across five Doctoral Programs (Biochemistry, Biology, Chemistry, Physics and
Psychology). We have been successful in this programmatic approach for many years as a RISE (R25)
funded institution (2000-2024). Our RISE doctoral trainees have, on average, completed their PhD at higher
rates and in less time than the average of PhD students in these doctoral programs. Furthermore, the
application pools through which PhD students come to pursue their thesis work at Hunter is remarkably
diverse. Individuals from underrepresented (UR) minority groups represent 29.3% of the PhD students
matriculating in the five participating doctoral programs over the past five years. This robust pipeline of IMSD-
eligible matriculants will enable the proposed program to effectively contribute to increasing diversity in the
biomedical research workforce. The proposed IMSD program will build on our strengths to further improve the
skill sets and outcomes of our trainees across 3 domains: science communication, big data analytics,
and holistic career development. These skill sets are crucial to develop and enhance in the early years of
doctoral training (years 2-4) as we propose. Program activities will enable trainees to develop 1) resiliency in
science, 2) time management strategies, 3) enhanced critical thinking, and 4) effective mentor/mentee
relationships. Additionally, Fellows will engage in teaching undergraduate labs and courses to develop their
science communication and leadership skills, including academic and professional confidence. Program
activities will also focus on developing skills in grantsmanship, large data set analyses, and oral
presentations. All program activities will assist our students to 1) Attain PhD program landmarks/milestones in
a timely manner, 2) Develop skills in critical thinking, writing, and science communication; 3) Gain additional
training in technological skills that support their research and career interest; and 4) develop skills in leadership
that support conducting ethically responsible and rigorous science investigation. The Fellows will also benefit
from the experience of their mentors. The 35 participating faculty were recruited for their funding, productivity,
and success in student development/mentorship, as well as their active engagement in their Doctoral
Programs (including service on admissions and recruitment committees). Our Fellows will also have the strong
institutional support of both Hunter College and the CUNY Graduate Center (the administrative hub for
graduate studies at CUNY). Both institutions have a long-standing commitment to supporting the development
of UR students in the sciences and, thus, a keen interest in supporting this proposed new IMSD program. Both
institutions view this program as necessary and integral to their missions, as an impactful mechanism to
support UR scientist entry into the biomedical research workforce.

Public health relevance
PROJECT NARRATIVE / RELEVANCE STATEMENT Hunter College of the City University of New York (CUNY) is committed to the mission of diversifying the U.S. biomedical workforce. The IMSD Program at Hunter College will support the research training efforts and professional development of underrepresented predoctoral students in the biomedical sciences, preparing them to successfully complete the Ph.D. and obtain postdoctoral-level positions in science. Thus, this program will prepare the next generation of diverse scientists to engage in research to benefit public health.